Virulence mechanisms in the emerging pathogen Kingella kingae

Kingella kingae is an invasive gram-negative pathogen that has been recognized recently as a leading cause of septic arthritis and osteomyelitis in young children, accounting for up to 78% of cases in children <4 years old. Estimates indicate that over 15,000 cases of septic arthritis and osteomyelitis occur annually among children in the US, with the peak incidence in the first 3 years of life. Complications of septic arthritis and osteomyelitis in children include abnormalities in bone growth, limitation of joint mobility, unstable joint articulation, and chronic joint dislocation, resulting in residual skeletal dysfunction in 10-25% of cases. Based on epidemiologic data, the pathogenesis of K. kingae disease is believed to begin with colonization of the upper respiratory tract and to involve invasion of the bloodstream and spread to joints, bones, and sometimes other sites. In recent work, we established that type IV pili are essential for K. kingae adherence to respiratory epithelial cells, suggesting a critical role in colonization of the upper respiratory tract. Further analysis demonstrated that full-level pilus-mediated adherence is dependent on a trimeric autotransporter protein called Knh. Additional studies revealed that isolates of K. kingae produce a polysaccharide capsule that interferes with Knh-mediated adherence when pili are absent. There are four different polysaccharide capsule types, including three that account for all cases of invasive disease and one that is found only in carrier isolates. Based on analysis of our prototype invasive isolate, encapsulation is essential for full virulence in an infant rat model of invasive disease. In the present proposal we will elucidate the interrelationship between type IV pili, the Knh protein, and the polysaccharide capsule as determinants of K. kingae adherence to respiratory epithelial cells. In addition, we will examine the role of pili, Knh, and capsule in a rhesus macaque monkey model of upper respiratory tract colonization. We will also elucidate the pathogenic and immunologic properties of the four K. kingae polysaccharide capsule types. The proposed studies will yield an improved understanding of the pathogenesis of disease due to an understudied pathogen that is being recognized increasingly as an important source of morbidity in young children, will define the mechanism that underlies a novel model of interaction between an encapsulated pathogen and host cells, and will define the pathogenic and immunologic properties of newly discovered polysaccharide capsules with unusual structures.

Public health relevance
Kingella kingae has emerged as the leading cause of septic arthritis and osteomyelitis in young children, accounting for up to 78% of microbiologically proven cases in patients between 6 months and 4 years of age. Based on population estimates, there are over 15,000 cases of septic arthritis and osteomyelitis among children in the US each year, with the peak incidence in the first 3 years of life and long-term complications occurring in 10-25% of patients. The results of the proposed studies will yield an improved understanding of the pathogenesis of disease due to K. kingae and will lay the foundation for developing a capsule-based vaccine to prevent K. kingae disease.